Data Management Core

PROJECT SUMMARY
The Northwestern HeartShare Data Translation Center (DTC) Data Management Core will leverage prior
leadership and experience in the field of machine learning for the identification of novel heart failure with
preserved ejection fraction (HFpEF) subtypes, along with a track record of leading data management for multi-
center studies, to facilitate multi-dimensional, multi-omics analyses (including machine learning/artificial
intelligence) for the entire HeartShare program. The HeartShare Data Management Core includes a highly
integrated team of individuals from a variety of disciplines with expertise in data coordinating center operations,
statistics, machine learning, omics, and HFpEF. These experts will work in concert to achieve the following
specific aims: (1) to develop procedures and standards for data pooling, cleaning, and harmonization of all data
from cohorts and trials; compile the data as a shared resource for the research community; and host these data
on BioData Catalyst as part of the retrospective component of HeartShare; (2) to integrate self-reported data,
home monitoring data from mobile health (mHealth) technologies, environmental data, electronic health record
(EHR) data (including natural language processing [NLP] techniques), deep phenotyping data, and outcome
data into a core data resource for the prospective component of HeartShare; (3) to create integrated biorepository
and imaging repository resources; coordinate these resources with TOPMed; and facilitate automated deep
learning analyses of images relevant to HeartShare; and (4) plan and facilitate advanced analytics (multi-omics
and machine learning analyses) to identify HFpEF subtypes and the pathobiological basis underlying these
subtypes. The Data Management Core will also ensure efficient visualization, reporting, and communication of
findings; and we will work with BioData Catalyst experts in our Data Portal Core to transition publicly available
data into cloud storage, implement governance within BioData Catalyst, and make tools and workflows cloud
compatible.